CLINICAL AND HORMONAL EFFECTS OF GROWTH HORMONE RELEASING PEPTIDE AND GHRP+GRF

Growth hormone releasing peptide (GHRP) plus GRF may be much more effective than either peptide alone in releasing GH. This study will determine the efficacy of GHRP and GHRP plus growth hormone releasing factor in stimulating GH secretion, the dose response relationship and evaluate its safety in human subjects.